Data science approaches to classify aggressive tissue phenotypes and predict disease-free survival in HPV-negative head and neck squamous cell carcinoma (HNSCC)

PROJECT SUMMARY
Data science approaches to classify aggressive tissue phenotypes that impact survival in HPV-
negative head and neck squamous cell carcinoma (HNSCC)
Head and neck squamous cell carcinoma (HNSCC) is a potentially fatal disease with a reported 5-year overall
survival of 64.5 percent. Despite decades of research into the molecular pathogenesis of HNSCC, researchers
have yet to identify reliable prognostic factors to implement into clinical practice to guide treatment decisions
beyond conventional TNM (tumor, node metastasis) staging. Efforts to correlate gene expression with
aggressive histopathologic phenotypes, such as nodal disease and perineural invasion, have intensified with
the increasing availability of sequencing data. However, singular tumor markers such as TP53 mutational
status have not proven statistically significant in predicting recurrence or survival. Rather, clinical studies
suggest that differences in histopathologic factors may explain differences in survival among patients within the
same TNM stage. Consequently, there is a pressing need to elucidate genetic differences between indolent
and more aggressive tissue phenotypes in HNSCC. Furthermore, the molecular pathways driving these
aggressive tissue phenotypes HNSCC remain inadequately understood, and their presence is analyzed
through visual examination alone, a method prone to imprecision and potential diagnostic oversights. To this
end, a more precise evaluation method based on molecular data could enhance the detection of adverse
histopathologic features that may lead to recurrence and decreased survival. This project aims to delineate
molecular variations within tumors based on distinct histopathologic features and employ machine learning
techniques to construct a predictive model using molecular data. This model would offer clinicians a more
objective means of identifying adverse prognostic tissue phenotypes, potentially leading to improved
stratification of patients into low-risk and high-risk groups for disease progression. Secondly, our findings will
shed light on the underlying molecular pathways driving different histologic phenotypes that can open new
avenues for targeted therapeutic interventions. Using existing data repositories from TCGA and DBGap as well
as a multi-institutional cohort of cases (Rutgers, Indiana, Columbia), a key feature of this project is to apply
machine learning methods on large-scale molecular data to develop an algorithm that can accurately predict
the presence of aggressive disease. Dr. Yingci Liu will lead this research initiative under the K08 award
proposal, with the goal of developing expertise in computational genomics and machine learning to establish
an independent translational research program in computational genomics and head and neck cancer. Dr. Liu
will receive support from a robust, multidisciplinary mentoring team consisting of experts in oncology, machine
learning, and head and neck cancer, which includes Dr. Shridar Ganesan, Dr. Antonina Mitrofanova, and Dr.
Flora Momen-Heravi.

Public health relevance
PROJECT NARRATIVE Evaluating HPV-negative head and neck squamous cell carcinoma into high-risk and low-risk categories for disease progression and recurrence is crucial in determining the need for adjuvant chemoradiation . Currently, this assessment relies on primarily histopathologic analysis, which is limited by tissue sampling issues and variability in pathologists’ interpretation of tissue morphology. This project aims to develop an algorithm that integrates histopathologic and molecular biomarkers, providing a more objective approach to risk stratification and improving diagnostic accuracy.